Commercialization readiness for a 3D image guidance system to support interventional procedures in the spine and pelvis

PROJECT SUMMARY/ABSTRACT
An estimated 100 million Americans suffer from chronic pain conditions, costing the US economy
>$500B/yr. Although chronic pain can be treated non-pharmacologically, long-term opioid therapy remains a
common treatment, with accompanying increase in risk of hospitalizations, substance abuse disorders, and
death. In 2018, over 10 million patients were prescribed long-term opioid therapy for chronic pain, even though
over one-third of opioid-related deaths are directly related to pharmaceutical opioid use for chronic pain. In
short, the US healthcare system has not met the demand for non-opioid interventions, which has resulted in
continued reliance on long-term opioid use for treating chronic pain. The current non-pharmacological standard
of care for chronic back pain intervention (present in >40% of chronic pain cases) consists of targeted joint
injections, nerve blocks, and nerve ablation performed under fluoroscopic image guidance. Reliance on
fluoroscopy for pain management injections is a key structural barrier in the care-delivery stream due to capital
equipment costs, facilities expenses, and staffing constraints. Only modest growth in procedures occurred in
recent years despite increased demand for chronic pain services, implying that the healthcare system is
operating at full capacity. There is a pressing need for an alternative guidance solution that matches the
efficacy of fluoroscopy but can be employed in a physician office setting to increase access to and decrease
the cost of interventional pain services.
This commercialization readiness pilot (CRP) project focuses on the generation of strategy to
demonstrate the clinical and economic value proposition for the Accuro 3S, a mobile, bedside system that
produces intuitive fluoroscopy-like reconstructions of spine anatomy and enables real-time needle guidance for
pain management injections at the patient bedside while reaching a cost >5x less than fluoroscopy. In the first
specific aim, RIVANNA will partner with external experts to conduct a multi-phase market research study,
develop a reimbursement strategy, and develop a Budget Impact Model (BIM) and Cost Effectiveness Analysis
(CEA). These elements, in combination, are expected to generate an all-inclusive Clinical Evidence Generation
Strategy that RIVANNA can execute to best position the Accuro 3S for commercialization via future
investment from strategic partners and product-specific reimbursement petitioning. In the second specific aim,
RIVANNA will partner with medical device manufacturing experts to expedite the manufacturing, validation,
and regulatory approval of a sterile consumable so that it will be available when clinical trials commence.
Completion of this commercialization project will bridge critical gaps in the Accuro 3S commercialization
path, enabling RIVANNA to maximize early market penetration and work toward the long-term vision of
improving outcomes in chronic pain management by changing the standard of care.

Public health relevance
PROJECT NARRATIVE Chronic pain conditions impact an estimated 100 million Americans, result in total healthcare expenditures of more than $500 billion per year, and are a key contributor to the US opioid epidemic. Expanding access to interventional pain medicine services is crucial for decreasing the use of long-term prescription opioid treatments for managing chronic pain, but the reliance on fluoroscopic imaging guidance places bottlenecks in the care-delivery stream and significantly limits patient access to these interventional procedures. Therefore, the goal of this project is to develop commercialization strategies that will maximize early market penetration of a mobile, bedside system that provides intuitive fluoroscopy-like visualization of spine anatomy without the use of ionizing radiation, enables real-time needle guidance during interventional procedures performed in the spine, and increases patient access to non-opioid based therapies for alleviating symptoms associated with chronic pain.